Testing of a patient-centered e-health implementation model in addiction treatment

Project Summary/Abstract
A team of researchers from the Center for Health Enhancement Systems Studies (the Center) at University of
Wisconsin–Madison College of Engineering and the Iowa Department of Public Health will test the
effectiveness of the Network for the Improvement of Addiction Treatment-Technology Implementation (NIATx-
TI) framework in implementing the ACHESS substance use disorder (SUD) treatment and recovery app.
ACHESS uses smartphone technology to provide continual access to SUD care and has improved treatment
outcomes in a randomized trial as well as in real-world SUD treatment settings with patients with opioid and
alcohol use disorders. Despite its evidence base and 74% of SUD treatment patients possessing a
smartphone, ACHESS is currently used in <1% of settings that provide SUD treatment. ACHESS is not unique
in this regard; health care, in general, has low patient-centered technology adoption rates. This low adoption
highlights yet another implementation gap and the need for the dissemination and implementation field to
develop approaches to facilitate adoption of the growing list of evidence-based e-health technologies. The two
strategies to be tested in increasing ACHESS use are the NIATx-TI framework and product training, followed
by ongoing technical support. The NIATx-TI framework developed by our Center builds on our experience in
applying the NIATx organizational change model in more than 3,300 organizations. NIATx-TI combines the
systems engineering principles embedded in the NIATx organizational model with validated technology
adoption techniques. NIATx-TI was piloted successfully in our Center's 7-state project, “Promoting the Use of
Technology to Improve Treatment and Recovery Learning Collaborative,” and led to a 2-fold increase in clients
receiving distance treatment during the pilot study. The RE-AIM framework will be used to measure the impact
of the 2 interventions in n=16 SUD organizations in Iowa (with n=8 organizations per each arm). A qualitative
and cost analysis will be used to develop a better understanding of the implementation process. Iowa was
selected as a research setting because of its diverse population of service providers, high participation rates in
other national projects, strong data reporting systems, and because the Iowa Consortium for Substance Abuse
Research & Evaluation will provide strong local support for the study. SUD treatment providers in Iowa and
across the country need the effective treatment supports that evidence-based mobile technologies can provide
when successfully implemented. ACHESS and other promising evidence-based patient-centered technologies
are positioned to alter SUD treatment and its outcomes. Through testing the NIATx-TI framework and typical
product training, this trial will yield a deeper understanding of how to successfully implement ACHESS and
other promising evidence-based technologies.

Public health relevance
Project Narrative Mobile phone apps such as ACHESS offer continual addiction recovery support, expanding the availability of effective addiction care. Yet, the low rates of use of ACHESS and other patient-centered e-health addiction treatment technologies underscore the need for effective, systematic approaches to adopting technology that supports patient recovery outside the clinic walls. The proposed research will test the ability of the NIATx- Technology Implementation (NIATx-TI) Framework and traditional technology product training to reduce the gap between e-health research evidence and practice and help treatment organizations and consumers benefit from the emerging technological advances in addiction treatment and recovery.